Impact of Depression on Alzheimer's disease: Prenatal Immune Origins and Shared Impact of Sex

“Impact of Depression on Alzheimer's disease: Prenatal Immune Origins and Shared Impact of Sex”
Project Summary
With the substantial increase in aging of the population, early prevention of Alzheimer’s disease (AD) is one of
the most important public health and economic challenges of our time. AD is associated with major depressive
disorder (MDD), and both have twice the frequency in women than men. However, the shared pathophysiology
that underlies MDD and AD is not well known. We will test the hypothesis that this shared risk has fetal origins
that involve abnormalities in immune-stress and vascular pathways with sex-dependent consequences. We are
uniquely poised to examine this for the first time in humans using our 60-year prospective prenatal cohort of
adults, followed since 2nd/3rd trimesters of gestation and tested recently at ages 44-57 in MH090291. In that
study, we investigated the fetal programming of sex differences in memory circuitry aging, following 212
discordant siblings (one exposed to preeclampsia (PE) or fetal growth restriction (FGR) and one unexposed)
wherein we showed PE/FGR associated with maternal prenatal immune activation abnormalities in TNF-, IL-
10, and IL-6. We propose to follow these siblings further to investigate later midlife memory decline over 8
years, neurovascular dysfunction, and preclinical AD pathology assessed as amyloid deposition. We will use
the same multimodal imaging as in MH090291 (structural, functional, and diffusion brain imaging--
sMRI/fMRI/dMRI) and same measures of verbal learning/memory, coupled with new measures of
neurovascular function based on retinal imaging, novel transcriptomic analyses in the adult offspring’s
peripheral blood mononuclear cells measuring innate immune gene expression, and amyloid deposition based
on PiB PET imaging. We postulate that prenatal maternal biomarkers, indicating in utero immune disruptions at
mid-gestation, coupled with innate immune gene expression, will be related to sex-dependent adult outcomes
in later midlife. Further, we will test whether associations between prenatal inflammatory biomarkers and sex-
dependent AD risk and neurovascular dysregulation are mediated by sex-dependent risk for MDD. Our lifespan
perspective is an innovative approach that will identify potential therapeutic targets for AD associated with
MDD and vascular function that are sex-dependent and can be applied to early periods for intervention prior to
disease onset.

Public health relevance
“Impact of Depression on Alzheimer's disease: Prenatal Immune Origins and Shared Impact of Sex” Narrative Alzheimer’s disease (AD) is one of the most important public health challenges of our time. We have an unprecedented opportunity to link fetal immune system disruptions with sex differences in adult depression, early AD pathology, and neurovascular dysfunction 60 years later, integrating associations between mood, memory, and one’s sex.